Integrative transcriptional and epigenomic modeling of xenobiotic-activated gene regulatory networks

PROJECT SUMMARY/ABSTRACT
The environmental contaminant 2,3,7,8-Tetrachlorodibenzo-p-dioxin (TCDD) is one of the most potent and
persistent toxicants known. TCDD and other dioxin-like chemicals are primarily ingested through food, and can
cause various adverse effects ranging from immune suppression to hepatotoxicity and developmental
alterations. Despite gradually decreasing environmental and body burdens, dioxin exposure remains of
particular concern in utero, in breastfed infants, and specific populations reliant for food on locally caught fish
and wildlife. The aryl hydrocarbon receptor (AHR), a ligand-inducible transcription factor, mediates virtually all
of the toxic effects of dioxins. Nearly four decades after its discovery, the AHR remains an enigmatic molecule
with a variety of endogenous roles in addition to its function as an environmental sensor. Our recent analysis of
the AHR signaling network in mouse liver showed that direct AHR binding to cognate sequences in promoter
regions of target genes explains only about 10% of TCDD-induced gene perturbations. In addition, it is unclear
why humans are much less sensitive in responses to TCDD than rodents. These gaps in our knowledge make
it difficult to estimate the risks of human exposure to dioxins. Our overarching hypothesis is that tissue- and
species-specific alterations in gene expression induced by AHR activation, which in turn lead to dioxin toxicity,
are determined by a combination of local chromatin accessibility, AHR binding in gene regulatory regions, and
AHR-mediated long-range chromatin interactions. We propose to use an innovative combination of functional
genomic experiments, computational modeling, and targeted epigenome editing (CRISPRi) to develop a
predictive model for AHR-mediated tissue- and species-specific gene regulation, and to reconstruct the AHR
transcriptional regulatory network in human vs. mouse liver and B cells. We will draw on both AHR-specific
data generated in this project, and the NIH ENCODE and Roadmap Epigenomics projects, which have
collectively made available 10,000+ genomic and epigenomic data sets from more than 400 human cell lines
and tissue types. In Aim 1, we will compare genome-wide chromatin accessibility of mouse and human
hepatocytes and B cells in the absence and presence of TCDD. In Aim 2, a novel predictive model for
genome-wide AHR binding will be developed based on ChIP-Seq, chromatin accessibility and histone
modification data. In Aim 3, we will identify and predict the differential expression of AHR target genes in
mouse and human from AHR binding sites in regulatory DNA and AHR-mediated long-range interactions. The
overall impact of our model will be improved mechanistic understanding of tissue-and species-specific gene
regulation by the AHR in unprecedented genome-wide detail. Our long-term goal is to develop a genome-
based quantitative framework for human risk assessment of chemicals that dysregulate core transcriptional
regulatory pathways.

Public health relevance
PROJECT NARRATIVE Even with reduced body burdens, human exposure to the highly toxic compound 2,3,7,8-Tetrachlorodibenzo-p- dioxin (TCDD) and other dioxin-like chemicals remain a public health concern, especially for vulnerable populations like infants. While most biological effects of TCDD are known to be mediated by the aryl hydrocarbon receptor (AHR), the identity of specific genes connecting AHR activation to toxic outcomes of TCDD exposure remains unknown. Here we propose to combine functional genomic experiments, computational modeling, and targeted epigenome editing to map AHR-mediated gene regulatory networks and predict TCDD-induced changes in gene expression in mouse vs. human liver and B cells.